Optimizing speech motor learning with neuromodulation: Behavioral outcomes and neural mechanisms

PROJECT SUMMARY/ABSTRACT
Stroke is a leading cause of disability in the United States, frequently leading to speech impairment that
creates barriers to participation in professional, social, and family settings. While recovery can be promoted
with speech motor learning treatment, residual disability remains a prominent issue. The long-term goal of this
research is to enhance intervention outcomes for individuals with acquired speech impairment by combining
theoretically-guided behavioral intervention with targeted neuromodulation. The main objectives of this
proposal are to verify the role of left ventral premotor and motor cortices in speech motor learning and to
establish that transcranial direct current stimulation (tDCS) can enhance speech motor learning treatment by
strengthening the cortical speech network. The central hypothesis of this proposal is that speech recovery in
chronic stroke can be improved by stimulating perilesional left ventral premotor and motor cortices, thereby
promoting their engagement during speech motor learning treatment and strengthening the cortical speech
network through associative learning. The central hypothesis will be tested by pursuing three specific aims: 1)
Establish the neural regions that underlie tDCS-facilitated speech motor learning; 2) Determine the extent to
which active tDCS with individualized electrode placement can enhance speech motor learning intervention
relative to sham tDCS in impaired speakers with apraxia of speech; and 3) Determine the functional
connectivity changes associated with speech motor learning-based intervention with active vs. sham tDCS in
impaired speakers with apraxia of speech. Under the first aim, the proposed research will systematically verify
the role of left ventral premotor and motor cortices in tDCS-facilitated speech motor learning using three
controls: electrode polarity, electrode position, and presence of active current. For the second aim, single-
subject intervention experiments will be used to evaluate the extent to which tDCS enhances apraxia treatment
outcomes, using individualized current modeling to target left ventral premotor and motor cortices. The third
aim determines the extent to which the treatment conditions in Aim 2 can change functional connectivity
measured with resting-state functional neuroimaging. The proposed research is innovative, in the applicant's
opinion, because it combines practice-based speech treatment with targeted tDCS to intensify Hebbian
plasticity and measures the extent to which this approach changes functional connectivity in the speech
network. This research will be significant because it will establish the combined effectiveness of speech motor
learning treatment and tDCS in AOS, an understudied condition. Understanding the interaction of treatment
and neuromodulation will build capacity to optimize chronic stroke recovery, with direct application to
enhancing speech skills to improve communication ability and quality of life.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on combining theoretically-guided behavioral intervention with neuromodulation to optimize treatment for acquired speech deficits subsequent to stroke, which pose a significant barrier to effective communication, and limit participation in professional, social, and family environments. While current treatments can promote some limited recovery, residual disability remains a problem, and understanding the mechanism of recovery will create the potential for significantly improved individualized outcomes. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to reducing illness and disability.